Chemistry and Biology Interface (CBI) NIH T32 Training Grant

CBI T32 Abstract: The objective of this Chemistry-Biology Interface (CBI) Predoctoral Program
is to provide cross-disciplinary training to talented students with diverse interests that will enable
them to apply the mechanistic and atomistic perspective of chemistry to important biological
problems. The program brings together 42 faculty trainers from eight academic units at the Univ.
of Delaware representing disciplines of organic chemistry, analytical chemistry, biochemistry,
chemical biology, structural biology, molecular biology, cell biology, systems biology,
bioinformatics, molecular biology, cell biology, microbiology, virology, and developmental biology.
The faculty trainers include both new and established researchers with vibrant research programs
in biomolecular science and experience in training graduate students. A diverse trainee group
(with a focus to recruit and retain URMs) with varied educational backgrounds are selected on
the basis of their desire to explore multidisciplinary problems at the interface of chemistry and
biology, their GRE scores, undergraduate GPA, letters of recommendation and research
background. Eight trainees are admitted each year through existing graduate programs of
Chemistry & Biochemistry, Chemical & Biomolecular Engineering, Biological Sciences or other
CBI trainer departments and university supported for their first year. A second, funded track of
admission to the CBI program is outlined; students with a strong interest in research at the
interface of chemistry and biology will be invited to apply at the end of their first or second year of
their graduate studies. All trainees will satisfy the degree requirements for their specific
departmental program in addition to the requirements for the CBI program. Three one semester
courses will be selected from a diverse list of course offerings from six departments. A key feature
of the CBI program is the laboratory rotations each trainee undertakes to provide them with hands-
on experience in the different disciplines. Between courses and laboratory rotations students are
expected to have exposure to concepts and methods from the atomistic to the cellular. Students
are empowered by this background to think creatively about biological and chemical problems
that are relevant to human health. This proposal aims to provide students with a menu of university
funded internships (local pharmaceutical/biotech firms, National Labs and new collaborations to
enhance their career development. All trainees are required to participate in a series of quarterly
responsible conduct of research (RCR) workshops, a 2-day University sponsored RCR and a
January workshop of data reproducibility and rigor. A weekly seminar series brings the CBI
community together and provides trainees numerous opportunities to present their own work, as
well as learn from both faculty trainers and outside speakers. Each trainee undertakes an
intensive independent research experience culminating in a dissertation representing an original
contribution to a field at the chemistry-biology interface. This program follows and builds on a
successful 25-year model for training scientists with both broad scientific knowledge as well as
solid foundations in a chosen core discipline. With this Mentoring Supplement, we aim to broaden
our efforts in mentor training with a focus on culturally aware mentoring and create an environment
where supportive mentoring is championed.

Public health relevance
There have been no changes to the overall project narrative. This is a supplement for mentoring to support the original project narrative.